RESEARCH CORE

In selection of Research Subprojects for the CoE, Warren and Smalley selected projects that would address a diverse scope of rural health disparities in terms of demographic characteristics, geographical location, community vs. clinical populations, health outcomes, and level of prevention (e.g., secondary vs. tertiary). The significance of each individual project with regards to its population and outcome is detailed within the Research Sub

Public health relevance
project narratives. To facilitate the translation of the research findings into health disparities elimination action, both Research Subprojects involve testing of new educational/behavioral interventions that have been designed based upon previous work within disparity communities. Both projects will involve two-phased approaches: the first phase focused on refinement of the existing intervention framework to ensure its cultural sensitivity and to manualized the intervention, and the second phase focused on testing the effectiveness of the intervention.